Clinical Validation of DystoniaNet Deep Learning Platform for Diagnosis of Isolated Dystonia

PROJECT SUMMARY / ABSTRACT
Isolated dystonia is a movement disorder of unknown pathophysiology, which causes involuntary muscle
contractions leading to abnormal, typically patterned, twisting movements and postures. A significant challenge
in the clinical management of dystonia is due to the absence of a biomarker and associated ‘gold’ standard
diagnostic test. Currently, the diagnosis of dystonia is guided by clinical evaluations of its symptoms, which
lead to a low agreement between clinicians and a high rate of diagnostic inaccuracies. It is estimated that only
5% of patients receive an accurate diagnosis at symptom onset, and the average diagnostic delay extends up
to 10.1 years. There is, therefore, an urgent unmet clinical need to establish an objective and pathophysiologi-
cally relevant diagnostic test for isolated dystonia and to determine its clinical validity for accurate and fast di-
agnosis of dystonia. The objective of this project is to conduct parallel retrospective and prospective studies to
clinically validate the performance of DystoniaNet, a biomarker-based deep learning platform for diagnosis of
isolated dystonia. Supported by our strong preliminary data, our central hypothesis is that validated perfor-
mance characteristics of DystoniaNet are acceptable for its translation and implementation in the clinical set-
ting as an objective, accurate, and fast platform for diagnosis of isolated dystonia. We postulate that the avail-
ability of DystoniaNet platform in the clinical setting will significantly increase the accuracy of dystonia diagno-
sis and significantly decrease the time to diagnosis, especially in phenotypically complex and uncertain cases.
We will pursue the following two specific aims: (1) retrospective clinical validation of DystoniaNet for dystonia
diagnosis, and (2) prospective randomized clinical validation of DystoniaNet. The proposed research is innova-
tive because it is built on the novel conceptual and methodological concepts for clinical validation of a bi-
omarker-based diagnostic platform that specifically addresses the current unmet clinical need for dystonia
management. The proposed research is significant because it will advance the first objective diagnostic plat-
form for dystonia diagnosis from its discovery and analytical validation to clinical use, thus filling the critical clin-
ical gap in the standard of care of this disorder. Early detection and diagnosis of dystonia will enable its early
therapy and improved prognosis, having an overall positive impact on healthcare and patient’s quality of life.

Public health relevance
PROJECT NARRATIVE The proposed research aims to conduct retrospective and prospective studies for clinical validation of a DystoniaNet deep learning platform for the diagnosis of isolated dystonia. The proposed research is relevant to public health because the translation and implementation of a robustly validated, objective and accurate diagnostic approach of isolated dystonia is expected to have a significant positive impact on the clinical management of this disorder. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to developing and applying fundamental knowledge that will help to reduce the burdens of human disability.